Pilot and Feasibility Program

OVERALL SUMMARY:
The P & F program is designed to support highly innovative research relevant to personalized CF
medicine and to facilitate the transition of new and early-stage investigators to obtain extramural funding
and to sustain their individual research program. We have several new and early-stage investigators at
CCHMC, CSMC & UCCOM who are passionate in personalized CF medicine research. It is the intention
of the PCFC to encourage these investigators to develop an innovative research program that would
blaze new trails in the area of CF/CFTR related basic research and develop translational program with
personalized CF medicine theme.